Structure and functions of a bacterial Type IV effector complex

Project Summary
Bacterial pathogens use “effector” proteins as part of their virulence strategies to subvert host functions
and promote bacterial intracellular survival, proliferation and persistence. These effectors operate
individually or collectively to modulate cellular processes, usually in a functionally integrated manner.
Bacterial effectors may have antagonistic or convergent activities on cellular pathways or regulate each
other’s activities (as “meta-effectors”). How multiple effector activities are coordinated spatially and
temporally in host cells remains largely unknown. In our efforts to characterize mechanisms of intracellular
proliferation of the intracellular bacterium Brucella abortus, we have uncovered a physical interaction
between three Type IV secretion effectors - BspF, BspH and BspI - suggesting that they form a multi-
effector complex when delivered into host cells. BspF is a putative acetyltransferase that localizes to the
recycling endosome and interacts with the host protein ACAP1, a GTPase activating protein (GAP) of the
endocytic GTPase Arf6, thereby inhibiting Arf6 activity and retrograde vesicular transport to promote
Brucella intracellular growth. BspH and BspI remain poorly characterized but contain structural Armadillo
(ARM) repeats and a GAP domain, respectively, suggesting protein-protein interactions for BspH and host
GTPase modulation capabilities for BspI. Consistently, we found that BspI directly interacts with the host
GTPases Rac1 and Rab5. Moreover, we found that BspF, BspH and BspI interact in a complex associated
with early endosomal structures. We will test the hypothesis that these effector proteins intrinsically form
a multi-effector platform that coordinates host GTPase-modulating effector activities on endosomal
transport to promote bacterial intracellular growth. Aim 1 will determine key aspects of the structure and
assembly of the BspF:H:I complex, using computational, biochemical and structural biology approaches.
Aim 2 will i) determine the function of BspI and of the BspF;H:I complex in Brucella’s intracellular cycle and
ii) define functional interactions between BspF, BspH and BspI. The proposed research will address
seminal questions towards establishing a new paradigm of integration of bacterial effector functions with
broad impact to the field of bacterial pathogenesis.

Public health relevance
Project Narrative Many bacterial diseases are caused by intracellular pathogens that deliver proteins into host cells to remodel them into a niche of survival, replication or persistence. These so-called “effector” proteins act together to promote bacterial virulence, yet how their functions are coordinated in space and time remain elusive. We found that the zoonotic bacterial pathogen Brucella abortus injects into host cells three effector proteins that form an intracellular complex. This proposal aims to characterize the structure, assembly and functions of this unique multi-effector platform and determine whether it allows coordination of effector functions during the Brucella intracellular cycle.